Investigating the role of PLA2G2A/sPLA2-IIA in macular degeneration

Abstract
Age-related macular degeneration (AMD) is a leading cause of adult blindness with limited treatment options.
AMD can present in two forms: geographic atrophy (dry form) and choroidal neovascularization/ CNV (wet form).
Strong evidence links sterile inflammation to AMD pathogenesis, and the FDA has already approved two
complement pathway inhibitors for treating geographic atrophy (dry form). However, due to the limited
therapeutic impact and adverse effects of complement inhibitors and other approved drugs for both dry AMD and
wet AMD, there is an urgent need to identify novel therapeutic targets for AMD. Our recently published data and
preliminary studies identified secretory phospholipase A2-IIA (PLA2G2A/sPLA2-IIA), a pro-inflammatory
enzyme, as a key molecular player in AMD pathogenesis. AMD primarily affects the retinal pigment epithelium
(RPE) cells, with drusen underlying RPE cells as an early pathological biomarker of the disease. AMD iRPE
cultures and AMD donor eyes showed elevated PLA2G2A levels in drusen. Furthermore, pharmacological
modulation of PLA2G2A in AMD iRPE cultures reduced drusen. In addition, in a proof-of-concept experiment,
PLA2G2A overexpression led to AMD-associated pathological alterations (drusen, Bruch's membrane
thickening, CNV, and visual deficits) in aged C57BL/6J mice. Altogether, these studies provide strong evidence
for a "mutation-independent" pathogenic role of PLA2G2A in AMD. To critically evaluate the role of PLA2G2A in
AMD, in this proposal, we will utilize human donor eyes (Aim 1), and both in vitro (patient-iPSCs) (Aim 2) and in
vivo (transgenic mice) approaches (Aim 3). Ultimately, the proposed research has the potential to i) increase our
understanding of AMD pathobiology, ii) provide a relevant mouse model of AMD, and iii) yield a novel and
mutation-independent therapeutic target for AMD and potentially related macular dystrophies.

Public health relevance
Project Narrative Age-related macular degeneration (AMD) is a complex multifactorial disease that leads to vision loss. This projects will increase our understanding of AMD pathobiology and has the potential to provide a relevant animal model of AMD for mechanistic and therapeutic studies.